CORE B (Molecular Pathology Core)

Abstract/Summary:
The Molecular Pathology Core will be located at the University of Miami under the direct supervision of Dr.
Oliver McDonald, MD, Ph.D., with collaborative support from Dr. Ladan Fazlollahi, MD, MPH at Columbia
University. This Core provides several essential services to P01 investigators. The Molecular Pathology Core
interfaces with existing infrastructure at the University of Miami to coordinate the collection of high quality
tissue specimens (human and animal) so that an experienced gastrointestinal pathologist can process them
into slide-based formats (H&E stains, TMAs, specialized chemical stains, immunohistochemical stains) that are
suitable for histopathologic microscopic evaluation. The Core also annotates, stores, and tracks tissue
biospecimens as they are collected and processed. Most importantly, the Core provides expert gastrointestinal
pathology consultation and diagnostic slide review, including H&E morphology, special stain interpretation, and
immunohistochemical (IHC) evaluation. These basic Core services are required for successful execution of
P01 projects, all of which require in-depth histopathologic characterization of Barrett’s Esophagus (BE) and
esophageal adenocarcinoma (EAC). The grading of BE-associated glandular dysplasia, grading and staging
esophageal adenocarcinoma, evaluating of in situ protein expression in these lesions, and implementating of
quantitative scoring systems are amenable to statistical tests of significance in collaboration with the
Biostatistics Core.

Public health relevance
Narrative: The Molecular Pathology Core will oversee collection, storage, and organization of human and animal tissue specimens for P01 projects as needed. The Core will coordinate the processing of human and animal tissues through the Biospecimens Shared Resource and the Pathology Research Histology Lab. The Molecular Pathology Core will provide investigators with expert histopathologic, immunophenotypic, and quality control analysis of all processed human and animal tissue samples for this P01.